Spatial and temporal tumor-immune co-evolution and interactions that model lung adenocarcinoma development

PROJECT SUMMARY
Lung adenocarcinoma (LUAD) is the most frequent subtype of lung cancer and accounts for most cancer
deaths. Improved early detection has increased the number of LUADs diagnosed at earlier pathological stages,
thus warranting strategies to treat this growing patient subpopulation. Thwarting these advances is a very poor
understanding of early events that drive LUAD development and that thus would guide ideal approaches for
interception. While normal lung epithelia of LUAD patients were shown to display tumor-pertinent molecular
and inflammatory changes, it is not clear why a LUAD develops within a particular region in the lung. Whereas
the lung is ecologically rich with many cell populations that partake in both physiological and pathological
processes, we still do not know how the properties and roles of individual cell populations, such as epithelial
and immune subsets, co-evolve and interact to instigate LUAD development from a specific niche in the lung.
In our preliminary efforts, we found by multi-region single-cell sequencing remarkable evolution of the
properties and transcriptomic features of multiple cell subsets and states (e.g., protumor immunosuppressive
phenotypes) across macro-space, such that cellular ecosystems and immune cell receptor repertoires were
more similar among LUADs and adjacent normal regions than with more distant normal sites. Also, such
spatial properties were progressively enriched along the pathologic continuum of matched human normal lung,
to preneoplasias, up to invasive LUADs. Our preliminary findings motivate the hypothesis that geospatially
and temporally evolving expression programs, properties, and interplay of epithelial and immune cells
model early development of LUAD from the normal and premalignant lung. In Aim 1, we will study LUADs
and matched multi-region normal tissues with defined spatial proximities from the tumors by single-cell RNA
and immune receptor sequencing in conjunction with analysis of mutations in the tumors to establish single-cell
maps of LUAD and immune co-evolution in space. Spatially modulated cell properties and states will then be
used to feed and train a machine learning model that portrays LUAD development from the lung ecosystem. In
Aim 2, we will single-cell decode tumor-immune co-evolution along the pathologic continuum of normal and
premalignant lung to LUAD as well as identify cell states and properties that are modulated by early immune
intervention. We will use temporal information in mice, along with human matched normal lung tissues,
preneoplastic lesions, and invasive LUADs, to iteratively validate and fine-tune the performance of our machine
learning model to portray LUAD development in time from the normal and premalignant lung. At the end of our
studies, we will have built new models that reliably portray LUAD evolution in space and time. By providing an
atlas of LUAD development in an accessible data portal, we also expect that our study will offer scalable
roadmaps for the scientific community to develop new strategies for treatment of this fatal disease.

Public health relevance
PROJECT NARRATIVE Lung adenocarcinoma (LUAD), even when detected in its early stages, exhibits very poor prognosis warranting continued improvements for its treatment. Efforts to treat LUAD are stymied by our poor understanding of how the tumor early on emerges from the complex lung ecosystem. Using unique and richly annotated human cohorts, experimental mouse models that faithfully recapitulate the disease, as well as state-of-the-art technologies that sequence individual cells and mathematical modeling, the proposed work seeks to unravel how LUAD develops across space and time, thus providing a foundation for developing new strategies for interception of this fatal disease.